Remote Data Enclave

Project Summary
Core E is the locus of organization and archiving of outcomes of data collections carried out at CDHA under
special conditions due to access restrictions. Staff in the core design, maintain and develop resources as needed
by CDHA affiliates and other researchers on health and aging in and off campus to access and analyze
restricted data. The Core strives to have in place a facility that is in tune with the newest technological
innovations and that adapts easily to changes in the technological environment. In this cycle we continue the
integration between Core E operations and those of the Federal Statistical Research Data Center (FSRDC) at
the University of Wisconsin-Madison during 2015.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is located in the Overall section of this proposal.